Center for Structural Biology of HIV RNA

Administrative Core
The primary goal of the Administrative Core will be to manage all reporting, regulatory, financial, logistic and
administrative matters of the Center for Structural Biology of HIV RNA, as well as facilitate collaborations and
scientifically enriching experiences, thereby providing an environment for CRNA investigators in which they can
put science first to the full extent possible. These aims will involve (1) establishing and maintaining an effective
management plan that supports the projects, scientific output, and personnel of the CRNA (2) supporting and
managing scientific interactions among CRNA investigators and (3) facilitating and promoting interactions with
the broader scientific community and other outreach.